MAGNESIUM HYDROXIDE EFFECT ON SERUM IRON LEVELS AFTER IRON INGESTION

Demonstrate that the administration of oral magnesium hydroxide will decrease iron absorption after a supratherapeutic dose of iron sulfate in humans.